Statistical Methods for Integration of Multiple Data Sources toward Precision Cancer Medicine

Project Summary:
The primary objective of this research is to develop novel statistical and computational tools to evaluate new
and existing cancer therapies for precision cancer medicine, with a principal focus on integrating multiple data
sources including randomized controlled trials (RCT) and real world data (RWD). All of the aims are motivated
by multidisciplinary collaboration. Evidence-based clinical decision making involves synthesizing available
research evidence from multiple resources, including RCT and RWD. Pivotal RCTs are the primary evidence
that established the oncologic equivalence or efficacy of local and systemic treatments. However, a recent
systematic review found little agreement between population-based RWD and RCTs when comparing the
same oncologic treatment regimens. This difference is thought to stem from the highly selective criteria used
for trial enrollment coupled with the rapidly changing nature of multidisciplinary cancer care. Moreover,
heterogeneous treatment effects by disease biologic tumor subtype on survival outcomes has not been
examined sufficiently in early RCTs. We will develop statistical tools and software to evaluate the agreement of
findings from RCTs and the real-world patient population, reassessing standard treatment guidelines on local-
regional therapies for early-stage breast cancer by patients’ clinical and tumor subtypes. While the proposed
methodology is agnostic to disease type, we will use breast cancer patients as proof of principle for the
approaches proposed.
The specific aims are: (1) to estimate and assess the agreement of treatment efficacy on survival outcomes
across multiple studies (e.g., RCT and RWD) using nonparametric calibration weights to adjust for treatment
selection bias and heterogeneity between studies; (2) to test the existence of a subgroup of patients with
enhanced treatment effect and predict subgroup membership of a treatment using a semi-parametric isotonic-
Cox model, and to develop a concordance-assisted learning tool for threshold identification to guide patient
treatment selection; (3) to infer the treatment effects on breast cancer-specific survival when the cause of
death is unknown in RWD by integrating data from RCT and RWD; (4) to estimate treatment effect for rare
subtypes of breast cancer by combining external aggregate data with individual-level data to improve inference
efficiency; and (5) to develop and disseminate publicly available, user-friendly software and facilitate the
reproducibility and applications of our methods to multiple existing databases, including large-population-level
data and RCT data for breast cancer research. The proposed research will advance general methodologic
development in comparative effectiveness and precision medicine research by efficiently integrating multiple
data sources. More importantly, the study findings could improve evidence-based treatment recommendations,
better informing clinicians to select optimal treatments according to patients’ tumor subtypes and other
characteristics, thus furthering clinical care via better integration of clinical science.

Public health relevance
PUBLIC HEALTH RELEVANCE: The primary objective of this study is to develop statistical models and methods for evaluating existing or new cancer treatments for precision cancer medicine when synthesizing data from multiple resources, including evidence from randomized controlled trials (RCT) and real world data (RWD). We will rigorously evaluate the agreement of findings from RCTs and RWD, as well as develop algorithms to select optimal therapies determined by patients’ tumor subtype and other clinical features. The clinical findings will improve cancer practice guidelines leading to enhanced patient outcomes; and the novel statistical tools will be applicable to a broad range of cancer research and to building evidence-based clinical practice.